TRITIUM NMR REVIEWS

Two tritium NMR reviews were prepared for the Encyclopedia of NMR, published in early 1996. Revision of these articles and review of galley proofs was required during this grant period. A full tritium NMR review was solicited some years ago by Jim Emsley as Editor for Progress in NMR Spectroscopy. Work on this review is now well-advanced, and it should be submitted in late summer 1996.